Evaluation of Smoke-Free Housing Policy Impacts on Tobacco Smoke Exposure and Health Outcomes

ABSTRACT. Tobacco use remains the leading cause of preventable death in the U.S., responsible for more
than 440,000 deaths annually, of which 41,000 are attributable to environmental tobacco smoke (ETS). The
federal Department of Housing and Urban Development (HUD) recently passed a rule that will require all public
housing agencies (PHAs) to implement smoke free policies in their developments. There is a strong rationale
for the new housing policy. Compared to the general public, residents in public housing are at excess risk for
ETS exposure for two reasons: (1) Despite overall declines in smoking over time, major disparities persist by
income level, education and race/ethnicity. Thus smoking rates among residents living in public housing, a
predominantly minority, lower income population, tend to be higher than in the general population. (2) Most
public housing residents live in multiunit housing (MUH), an environment that places all residents at elevated
risk for involuntary ETS exposure due to smoke accumulation compared to residents living in detached
housing. While prohibition of smoking in homes has promising implications for improving health, initiatives to
mandate smoke-free housing are still nascent. No empirical studies have objectively evaluated the impact on
health outcomes among residents. Estimated health consequences of such policies are currently based on
mathematical models, and only a few studies have measured change in resident ETS exposure before and
after implementation of housing-wide bans. These studies have mostly been small, with short follow-up
periods, and they have given only limited attention to studying the implementation process. To fill this gap, we
propose a large-scale natural experiment to examine the impact of the HUD policy on reducing ETS exposure
and improving health outcomes. The New York City Housing Authority (NYCHA) is the largest housing
authority in the United States, with more than 400,000 residents. Using a quasi-experimental longitudinal
design, we plan to monitor ETS before and after policy implementation (tracking every 6 months for 2.5 years
post-policy) in 200 apartments of non-smokers and common areas of 10 select high-rise NYCHA buildings,
and compare to ETS changes in 200 apartments in 10 demographically matched high-rise buildings in another
housing program, not subject to the smoke-free policy. Using geocoded administrative data, citywide NYCHA
resident health outcomes will be compared to residents in matched low-income census blocks. Finally we will
use survey data, qualitative interviews and focus groups to explore multilevel factors that influence the
implementation process and outcomes. This study leverages a strong, ongoing partnership of academic and
municipal government investigators, including experts at New York University School of Medicine, senior staff
at NYCHA, and leaders from the NYC Department of Health and Mental Hygiene. Findings will be used to
develop guidance for implementing SFH policies in public or private MUH settings nationally.

Public health relevance
PROJECT NARRATIVE The federal Department of Housing and Urban Development (HUD) recently passed a rule that will require all public housing agencies (PHAs) to implement smoke free policies in their developments. This study will evaluate the impact of the smoke free housing policy on environmental tobacco smoke exposure and health outcomes in New York City Housing Authority, the largest public housing authority in the US, as well as examine the implementation process. Findings will inform strategies for optimizing implementation and impact in NYCHA and public housing associations nationally.